Center for Modeling Non-Coding Disease Variants: Administrative Core

PROJECT SUMMARY/ABSTRACT: ADMINISTRATIVE CORE
The goal of the Admin/Coordination Core (ACC) is to provide administrative leadership and to guarantee that all
subunits are interacting and communicating efficiently. The three major functions of the ACC are (1) to provide
administrative and clerical support via organizing internal and external meetings, maintaining progress reports,
conducting outreach, etc. (2) to manage the award for this grant, and (3) to provide scientific project management
support. As the leadership core of the UCI Center for Modeling Non-coding Disease Variants (NODIVA), the
ACC’s goal is to ensure the success of the project by managing and supporting the different cores to identify
non-coding mutations from the clinic, develop animal and cellular models for these variants, and efficiently
distribute them to the scientific community. The ACC will coordinate regular interactions and meetings among
the Cores, the Steering Committee, External Advisory Board, and the NIH Program Officials to ensure project
progress and oversight. Additionally, the ACC will conduct outreach, recruitment, and collaboration efforts with
the research and clinical community and facilitate tracking of the Center’s activities and impact. In summary, the
ACC will play the key role in being the management engine for this project and will ultimately ensure its success.